Administrative Core

CORE 1 PROJECT SUMMARY
ADMINISTRATIVE CORE
The Administrative Core serves as the central node for all Projects and Cores of the Program Project Grant
(PPG) with the overarching goal of providing resources and facilitating interactions between the laboratories
involved. To accomplish this goal, two PhD level scientists have been appointed to distinct and complementary
roles within the Administrative Core. The PPG Administrative Director will specialize in providing administrative,
organizational, and communication support in order to facilitate the completion of program project goals (Aim 1).
To accomplish this aim, the PPG Administrative Director will organize regular meetings of the program project
group, plan an annual retreat including the Internal and External Advisory Boards, and oversee the fiscal
operations of all projects and cores to ensure compliance with the proposed budgets and timelines. The PPG
Project Management Director will be responsible for ensuring robust integration of project and core activities with
the highest level of scientific rigor and reproducibility of data (Aim 2). This aim will include the development
of a database of standard operating procedures (SOPs) for both experimental design and data analysis in order
to optimize the reproducibility of experiments across disease platforms and program project laboratories.
Additionally, the PPG Project Management Director will implement clear experimental pipelines to facilitate the
transition of samples and data across multiple program project and/or institutional cores. Finally, the members
of the Administrative Core will work together with Core #4 (Data Science Core) to support the internal and
external sharing of program project generated resources (Aim 3). For the internal sharing of data, Core #1 and
Core #4 will maintain the Lung Cancer Data Repository (LCDR) which will allow comparative analyses across
projects, species, and lung cancer subtypes. As the point of contact for both internal and external sharing of
resources, the Administrative Core is essential for fostering synergy among the program project members and
for ensuring the long-term success of the PPG team.

Public health relevance
CORE 1 PROJECT NARRATIVE ADMINISTRATIVE CORE The Administrative Core serves as the central node for all Projects and Cores of the Program Project Grant (PPG) with the overarching goal of providing resources and facilitating interactions between the laboratories involved. The Administrative Core has 3 goals: 1.) to provide administrative services including organization of meetings and annual retreats, 2.) to ensure robust integration of project and core activities with the highest level of scientific rigor and reproducibility of data, and 3.) to support internal and external resource and data sharing. These goals will be accomplished through the efforts of the leadership of the Core Leaders and two PhD level support staff, the Program Management Director and the Administrative Director.